Cerebrovascular and neurophysiological mechanisms of sleep-dependent memory impairment in older adults at risk for Alzheimer's disease

An estimated 6.5 million Americans over the age of 65 live with Alzheimer’s disease, a progressive
neurodegenerative disorder with no effective cure and the leading cause of dementia worldwide. Dementia is
typically preceded by a prodromal phase of Mild Cognitive Impairment (MCI), in which the earliest observed
cognitive changes are in memory. Research shows that up to 40% of dementia risk is due to modifiable risk
factors including sleep and cardiovascular risk factors that exacerbate Cerebral Small Vessel Disease (CSVD).
CSVD is found in approximately 80% of patients with concomitant Alzheimer’s disease pathology and
represents early, subtle changes to the cerebrovascular system. Taken together, the interplay of sleep and
CSVD is understudied, particularly in the context of Alzheimer’s disease-related cognitive changes in older
adults. The overall goal of this proposal is to examine the mechanisms linking CSVD to sleep-dependent
memory deficits seen in Alzheimer’s disease and to underscore the most relevant features of sleep that most
robustly predict CSVD. The Specific Aims address the role of CSVD in sleep-dependent memory deficits by
investigating fronto-temporal gray matter structure and local sleep expression as possible mechanistic links.
The present study design allows for a detailed characterization of participants across clinical and cognitive
domains. Participants undergo (1) magnetic resonance imaging (MRI), (2) two weeks of wrist-worn actigraphy,
(3) an overnight in-lab polysomnography study with high-density electroencephalography (hdEEG) and (4) a
memory task delivered in a sleep-dependent manner. This innovative, multi-modal study design has not been
widely implemented in older adults and lends to the applicant’s training goals of using advanced computational
and statistical methods to analyze high-dimensional datasets. This project will spearhead the applicant’s career
goals of becoming an independent investigator, utilizing computational methods to study biomarkers of
neurodegenerative disease. This project targets NIH’s goals for sleep research, including investigation of sleep
mechanisms underlying disease and risk reduction. UCI is an ideal institution to enact these study aims, as it is
a world-class research institution with modern neuroimaging facilities and a culture of collaboration. The
applicant has support from two experts in the fields of sleep research, Alzheimer’s disease, basic memory
science, and neuroimaging techniques. Collaborators listed on this proposal will provide additional support for
assessment of clinical factors, hdEEG, and statistical modeling. Insights from this proposal will fill in two major
gaps in our knowledge: (1) what features of sleep most strongly predict CSVD burden, and (2) what
mechanisms link CSVD to sleep-dependent memory in older adults. This project may reveal new therapeutic
targets for behavior-modifying interventions in sleep, inform precise screening in patients with disordered or
deficient sleep, and shape public health recommendations as the number of Americans impacted by
Alzheimer’s disease is projected to double by 2050.

Public health relevance
PROJECT NARRATIVE Over 6.5 million Americans over the age of 65 currently live with Alzheimer’s disease: a debilitating neurodegenerative disorder characterized by significant cognitive deficits. Research shows that up to 40% of dementia risk is due to modifiable risk factors, including deficient sleep and cardiovascular risk factors that exacerbate Cerebral Small Vessel Disease (CSVD). This project examines the mechanisms linking CSVD to sleep and sleep-dependent memory deficits related to Alzheimer’s disease, and lays the groundwork for advancement of behavioral interventions, refinement of screening, and development of public health recommendations for patients with disordered or deficient sleep.